NNLM Region 5: Reaching More People in More Ways

PROJECT SUMMARY/ABSTRACT – RML Program Core, NNLM Region 5 RML/University of
Washington (UW)
The Network of the National Library of Medicine (NNLM) Region 5 Regional Medical Library (RML) program
core aims to advance health equity, health literacy and data driven health by increasing community-driven
approaches for outreach and engagement through leveraging its existing member partnerships, developing
new partnerships with libraries and organizations sharing a mission to serve underrepresented populations and
also through cross regional and national NNLM collaborations. The RML will extend capacities through three
proposed subawards and a future small awards program. With a focus on current or potential network
members that are under-connected, and those organizations serving underrepresented groups, the RML will
offer competitive Community Technology Improvement awards. The RML will develop, implement, and
evaluate outreach and education programs, in collaboration with six other RML programs, national and
regional partners, the NNLM Training Office (NTO), and NNLM Evaluation Center (NEC). Each of these
partner touchstones enables UW RML to further advance the mission of NNLM and reach more people in more
ways.